SYV: A Mental Health Intervention to Improve HIV Outcomes in Tanzanian Youth

Young people living with HIV (YPLWH, 10-24 years of age) are a growing population that experience unique
mental health challenges that may compromise their HIV care. Despite the clear need, few evidence-based
mental health interventions exist to address the difficulties faced by this important population. The long-term
goal of our research is to provide developmentally appropriate, evidence-based mental health interventions that
effectively prevent and treat HIV in young people, especially in low resource settings where the majority of the
epidemic occurs. Sauti ya Vijana (SYV, The Voice of Youth), is a novel and innovative group-based mental
health and life skills intervention designed with and for Tanzanian YPLWH to address the mental health and life
challenges they have described in our prior research. The intervention consists of 10 group sessions (two joint
with caregivers) and two individual sessions delivered by trained young adults living with HIV who have
successfully transitioned to the adult clinic using a task sharing model that builds local capacity while overcoming
the critical shortage of mental health professionals in this setting. SYV incorporates components of Trauma
Informed-Cognitive Behavioral Therapy, Interpersonal Psychotherapy, and Motivational Interviewing that during
this critical neurodevelopmental period, when foundations of self and social regulation are realized, may prevent
or dramatically reduce severity of mental health symptoms. The overall objectives of this proposal are to support
positive coping strategies that bolster mental health and lead to improved HIV outcomes among YPLWH. The
central hypothesis is that SYV will be effective to improve antiretroviral therapy (ART) adherence and virologic
suppression in YPLWH in Tanzania. The rationale for this project is that by targeting mental health, which is
strongly associated with medication adherence, we will effectively improve adherence and thereby HIV viral
suppression. The central hypothesis will be tested in three aims in a hybrid type-1 effectiveness-implementation
trial. The first aim will use an individually randomized group treatment trial design to determine if SYV is effective
based on the primary outcome of 10% increase in virologic suppression (HIV RNA <400 copies/mL) among
YPLWH in the intervention arm compared to standard of care. The second aim will elucidate the mechanisms
by which SYV works and for whom it is most effective by evaluating potential moderators and mediators of the
intervention using structure equation modelling. Change in mental health, internal stigma, resilience and coping
are hypothesized to mediate the intervention effect, while age, sex, site, and baseline mental health symptoms
are hypothesized moderators. The final aim will evaluate implementation determinants and outcomes, including
cost effectiveness and sustainability guided by the Consolidated Framework for Implementation Research
(CFIR) to identify any implementation differences among sites. This project is significant because it is expected
to fill a critical mental health gap in caring for YPLWH in low resource settings with far-reaching implications on
individual health (HIV suppression) and population health (preventing transmission of HIV infection to others).

Public health relevance
Project Narrative The proposed research is relevant to public health because it employs a novel and innovative intervention that addresses mental health challenges and life skills to empower young people (10-24 years of age) to live a healthy and productive life despite living with HIV. An investment in developmentally tailored interventions to prevent or reduce mental health challenges in this important population will result in improved adherence to medication and viral suppression, leading to improved physical health and productivity in society. Relevant to the NIH HIV- related research priorities, this intervention addresses mental health as a comorbid condition and seeks to reduce HIV incidence through increased viral suppression that in turn reduces the risk of HIV transmission to others.